Effects of breast milk antibodies on neonatal intestinal immunity and host-microbe mutualism

Project Summary/Abstract
Breast milk is a key regulator of host-microbiome interactions in early life. In addition to nutrients, breast milk
contains cytokines, growth factors and antibodies, which help shape the composition of the microbiota and
regulate infant immunity to gut microbes. Accumulating evidence links breastfeeding with a decreased risk of
developing immune-mediated and metabolic diseases later in life. However, the specific components of breast
milk and the mechanism underlying these associations are currently lacking. Using a mouse model, our lab
discovered that mice deficient in breast milk antibodies mount increased mucosal T cell- dependent immune
responses, including elevated T follicular helper (Tfh) cells and germinal center (GC) B cells in the gut-draining
lymphoid tissues. This process is driven by microbes as germ-free mice lacking breast milk antibodies do not
generate aberrant mucosal Tfh and GC B cell responses. Due to the profound impact of the gut microbiota on
the development of the immune system coupled with the lifelong persistence of activated adaptive immune cells,
a current paradigm is that inappropriate adaptive immune responses to gut bacteria drive adverse health
outcomes in the long-term. The hypothesis of this proposal is that inappropriate adaptive immune responses to
resident gut bacteria resulting from the absence of breast milk antibodies drives persistent impairments in
intestinal homeostasis. To test this hypothesis, two aims are proposed. Aim 1 investigates the persistence,
localization, and phenotype of B cells activated in the absence of maternal antibodies via fate-tracking activated
GC B cells and flow cytometry. Aim 2 assesses the function of the T cell dependent adaptive immune response
on intestinal homeostasis. The comprehensive phenotypic and functional characterization of the novel T cell
dependent immune response that arises in neonates lacking breast milk antibodies will provide key mechanistic
insight on how breastfeeding contributes to long-term health. The studies outlined here will lay the groundwork
for the development of interventions and therapies to manipulate host relationships with the microbiota and
promote long-term health, particularly in neonates who are not breastfed.

Public health relevance
Project Narrative Breast feeding is associated with intestinal health, but the specific components of breast milk and the mechanisms underlying these associations are not fully understood. Building from our novel discovery that offspring fed with antibody deficient breast milk generate dysregulated intestinal immune responses, I propose to understand the consequences of these dysregulated responses as they relate to host-microbe mutualism. The resulting data may help advance the development of treatments or therapeutics aimed at promoting beneficial host-microbiome interactions in early life, particularly in children who are not breastfed.